A Predictive Model for Assessment of CSF Flow Through Ventricular Shunts

Project Summary
Hydrocephalus is a crippling condition which caused by an aberrant draining capacity of cerebrospinal fluid (CSF)
from the brain, affecting about 1-5 of every 1000 live births. This debilitating condition commonly manifests
itself in frequent headaches, seizures, and comas, with death as a likely outcome when left untreated. The
standard of care to alleviate this condition is ventriculoperitoneal shunting which diverts CSF away from the brain
ventricles, thereby reducing excess pressure build-up. CSF diversion systems or shunts are typically rudimentary
systems which contain a ventricular catheter, valve, and drainage tubing; this technology has experienced minimal
innovation since the 1960s. However, shunts regularly fail and require correction surgeries due to obstructions
and occlusions, leading to over 125,000 shunt revisions in the United States annually. Shunt revisions cost about
2 billion dollars in the United States annually for the nearly 1 million affected Americans. Hydrocephalus imposes
a huge financial, physiological, and psychological burden on patients and their health care providers, emphasizing
the urgent need to improve methods of monitoring and prediction of shunt failure.
To compound this issue, existing shunt failure diagnostics are costly, invasive, and/or harmful (in the case of ex-
tended radiation exposure in CT imaging). Typical shunt testing modalities include Magnetic Resonance Imaging
(MRI), Coherence Tomography (CT), and X-rays. Due to patient-to-patient variability in age, pathology, shunt in-
termittency, and shunt valve type, there is currently a lack of data with regards to flow dynamics in CSF diversion
systems. Most research efforts have primarily focused on the development of ‘smart shunts’ which inadvertently
couples complete shunt failure to sensor failure; this proposal seeks to provide accurate and real-time monitoring
of CSF flow in a noninvasive manner, the success of which could directly affect the quality of life of 1 million
Americans suffering with hydrocephalus and millions more around the world. This proposal will support the devel-
opment of a wearable sensor platform and processing algorithm that will culminate in a predictive model of shunt
failure to reduce hospital admissions and improve the quality of life for patients with hydrocephalus.
Success of this proposal will yield a fully flexible, soft, and wireless system which monitors CSF diversion (Aim 1
and Aim 2), leading to a validation trial of the integrated system in long term trials of both adult and pediatric patients
suffering with hydrocephalus. The completion of this work will also include the generation of a predictive model
which allows researchers to study long term CSF flow dynamics through ventricular shunts (Aim 3). Ultimately,
our methodology will enable us to collect a wealth of information to significantly aid healthcare professionals in
the proactive treatment of the devastating symptoms of hydrocephalus.

Public health relevance
Project Narrative This proposal will will yield a flexible, soft wireless system to monitor the functioning of CSF diversion systems (shunts) in patients with hydrocephalus, leading to a validation trial of the integrated system in both adult and pediatric clinical trials. The continuous collection of flow data through shunts will allow for the formulation of a comprehensive model for the predictive assessment of their failure modes. The generated data will yield predictive insights into CSF hydrodynamics, thereby providing a wealth of novel information to significantly aid healthcare professionals in the proactive treatment of the devastating symptoms of hydrocephalus.